Environmental and Epigenetic Modifiers of Susceptibility to Malignant Hyperthermia and Environmental Heat Stroke

Mutations in the skeletal muscle (SkM) sarcoplasmic reticulum (SR) Ca2+ release channel (Ryanodine Receptor
Type 1, RYR1), a component of the macromolecular complex that controls SkM excitation- contraction coupling
(ECC), are known genetic causes of Malignant Hyperthermia sensitivity (MHS) and Environmental Heat
Illness/Environmental Heat Stroke (EHI/EHS). MHS/EHS display incomplete penetrance, variable expressivity
and discordant inheritance. The reasons for this variability remain enigmatic. There are no effective treatments
for individuals with RYR1 pathogenic variants who experience life-threatening MHS/EHS episodes outside of
clinical settings (febrile pediatric patients, athletes, military personnel in hot environments).
Our goal is to develop approaches to prevent EHI-related deaths associated with RYR1 pathogenic variants.
We propose the existence of an environmentally sensitive, epigenetically regulated, feedback loop between
SkM and BAT that sensitizes MHS humans and mice to heat. Our specific hypotheses are: 1) Heat and
increased SkM activity drive metabolic and epigenetic changes in SkM and BAT to increase thermogenesis in
MHS mice. 2) Increased body temperature in MHS mice enhances SR Ca2+ leak, lactate production, AMPK
activation and metabolic changes in SkM, which, in turn, drive epigenetic modifications in SkM and BAT that
further enhance sensitivity to heat. 3) Heat-driven epigenetic changes are sex-biased and heritable and
contribute to discordance These hypotheses will be tested in 3 Specific Aims. Specific Aim 1: Define the roles
of heat, glycolysis, lactate, and adaptive thermogenesis in the enhanced sensitivity of MHS/EHS mice to heat.
Specific Aim 2: Define the role of RyR1 Ca2+ leak and AMPK activation in SKM on the enhanced sensitivity of
MHS mice to heat. Specific Aim 3: Determine if epigenetic changes driven by heat are heritable and sex biased.
Completion of these studies will elucidate fundamental molecular and epigenetic mechanisms that underlie
variability in EHS penetrance, expressivity, and genetic discordance, as well as provide new information on the
complex interplay of environment and genetics in these disorders. These data will lead to a new understanding
of the drivers of EHS episodes and, ultimately, to strategies for their prevention.

Public health relevance
Mutations in the gene that encodes the type I ryanodine receptor (RYR1) in skeletal muscle are the most common causes of malignant hyperthermia susceptibility (MHS) and environmental heat stroke (EHS). For unknown reasons, families with RYR1 mutations display variability in penetrance, expressivity, and genetic discordance. This project will define the molecular mechanisms that underlie variability in MHS/EHS penetrance, expressivity, sex-bias, and genetic discordance, as well as provide new information on the complex interplay of environment and genetics in these disorders.